Epi-genetic Programs in Cancer Progression

Project Summary/Abstract:
Much of current molecular oncology research is grounded on the paradigm that the behavior of cancer cells
and the tumors that they form is dictated by the mutant genomes that these cells have acquired en route to
entering into neoplastic/cancerous states. Implicit in this work is the notion that non-genetic mechanisms (that
are not directly influenced by DNA sequence) – notably changes organized by non-genetic (i.e., epigenetic)
regulatory circuits operating within a cancer cell – play a secondary role in dictating its behavior.
In fact, the majority of cancer cell traits may actually be governed by non-genetic regulatory programs that
operate in a relatively stable fashion to ensure that many of these traits are transmitted heritably from normal
cells-of-origin through multiple cancer cell generations during the course of multi-step tumor development. In
addition, activation within carcinoma cells of the cell-biologic program termed the epithelial-mesenchymal
transition (EMT) creates a second dimension of cancer cell behavior that is not dictated by the cells' DNA
sequences, acting by converting relatively benign carcinoma cells to malignant derivatives. These two non-
genetic regulatory mechanisms exert profound effects on the malignant progression of cancer cells and their
responsiveness to various forms of therapy. However, relatively little is known about how these non-
genetically determined traits of cancer cells are acquired and disrupted during tumor formation.
Super-enhancers (SEs) represent large aggregations of transcription factors (TFs) associated with a relatively
small number (several hundred) of gene promoters in both normal cells and cancer cells. These SEs are
responsible for orchestrating the differentiation programs of a variety of normal cell types that enables them to
become tissue-specialized cell types. The proposed research examines the disruptive effects of specific
oncogene-encoded proteins (and/or loss of tumor suppressor gene proteins) on the spectrum of SEs within
experimentally transformed human cells from a variety of normal cell lineages, with the goal of understanding
which SEs survive disruption and continue to influence the behavior of resulting tumorigenic cells (with respect
to their responsiveness to therapy and their malignant traits), and which are altered, resulting in the acquisition
of novel cancer cell traits. As a complement to these analyses will be an examination of the SEs associated
with the EMT programs activated in various types of transformed cells, these being activated either through the
induced expression of EMT-inducing TFs or the exposure of transformed cells to known EMT-inducing growth
factors and cytokines. By surveying SEs in normal cell types and their neoplastic derivatives, the proposed
work will generate an experimental platform that will enable many researchers to finally elucidate at the
molecular level why and how various distinct subtypes of human carcinomas naturally exhibit an array of key
biological traits or do so in response to imposed cytotoxic therapies.

Public health relevance
Project Narrative The bulk of cancer cell phenotypes, such as clinical progression and therapeutic responsiveness, are plausibly organized by non-genetic programs that are not illuminated by the much- practiced cancer genome sequencing. Two classes of non-genetic programs play major roles in organizing these phenotypes: differentiation programs inherited from normal cells-of-origin and the epithelial- mesenchymal transition (EMT). The proposed research will view changes and persistence of differentiation programs through analyses of the recently discovered super-enhancers – clusters of differentiation-associated master transcription factors – together with transcription factors organizing EMT programs, doing so in order to generate a systematic analysis of the non-genetic programs that play major roles in orchestrating the clinical behavior of human cancer cells.